A Phase 2 study of a Checkpoint Inhibitor in Men with Progressive Metastatic Castrate Resistant Prostate Cancer Characterized by a Mismatch Repair Deficiency or Biallelic CDK12 Inactivation

Alternative treatment approaches are urgently needed to improve quantity and quality of life of patients
with metastatic castration resistant prostate cancer (mCRPC). Immunotherapy in the form of checkpoint inhibition
has yielded auspicious results in many cancers, including lung cancer, melanoma, renal cell carcinoma, and
lymphoma amongst several others. The frequency of tumor-specific somatic mutations and hence neoantigen
formation strongly predicts for objective response to checkpoint inhibitors (CPIs). Prostate cancer is typified by
a relatively low mutational burden, so it is not surprising CPIs for mCRPC are largely ineffective, although
occasional responses have been observed. Over the last few years, mismatch repair deficiency (dMMR) and
biallelic inactivation of CDK12 (CDK12-/-) have been observed in a small subset of mCRPC patients. Importantly,
these genetic lesions have been associated with increased mutational burden due to increased point mutations
in the case of dMMR and heightened formation of focal tandem duplications in the case of CDK12-/-. Accordingly,
dMMR or CDK12-/- tumors are expected to be sensitive to CPIs.
The frequency of dMMR has been underestimated due to poor sensitivity of detection assays, which can
fail to detect allelic inactivation of MMR genes. Moreover, neither the frequency of dMMR or CDK12-/- nor the
response to checkpoint inhibition or dMMR or CDK12-/- tumors has been studied amongst Veterans. The
relevance of this knowledge gap amongst Veterans is highlighted by key demographic differences in Veterans
compared to the US population at large, which could in principle affect the frequencies of dMMR and CDK12-/-
as well as response to checkpoint inhibition. Using a sensitive next generation sequencing platform and
bioanalytic tool to detect microsatellite instability, a surrogate for dMMR, we predict that we can detect dMMR or
CDK12-/- in at least 15% of Veterans. Furthermore, we hypothesize that Veterans with dMMR or CDK12-/- will
exhibit a high response rate to checkpoint inhibition. We propose three aims:
1. Identify the frequency of dMMR and CDK12-/- as determined by NGS and a sensitive analytic tool for MSI
detection amongst Veterans with mCRPC. The MSI bioanalysis, known as mSINGS (microsatellite instability
by next generation sequencing), as well as targeted gene sequencing inclusive of CDK12 are built-in
components of OncoPlex, one of the CLIA-certified NGS platforms being implemented within the VA
Precision Oncology Program Cancer of the Prostate (POPCAP) network.
2. Perform an open label phase 2 clinical trial of pembrolizumab, an anti-PD1 CPI, to determine the efficacy of
pembrolizumab amongst dMMR and CDK12-/- mCRPC Veterans who have received prior AR signaling
≥
inhibitors. The primary endpoint will be response rate, defined as a composite of: objective response rate by
iRECIST 1.1, PSA50 at 12 weeks, radiographic progression free survival at 6 months.
3. Perform exploratory analyses to identify biomarkers of response and resistance to pembrolizumab in dMMR
and CDK12-/- mCRPC Veterans. For this purpose, we will acquire baseline and at-progression biopsies of
metastases as well as serial blood samples to investigate genomic, transcriptomic, proteomic, and immune
factors that contribute to response.
This study will result in enhanced understanding of the biology of mCRPCs amongst Veterans and the
identification of Veterans who respond to checkpoint inhibition, thereby benefiting from potentially life extending
therapy. In addition, exploratory/correlative analyses could identify molecular targets, the modulation of which
could potentiate the anti-tumor effects of checkpoint inhibition..

Public health relevance
Improving treatment of prostate cancer is critically relevant to Veterans’ health. Prostate cancer is diagnosed in approximately 12,000 American Veterans annually and accounts for one third of all cancer diagnoses in American male Veterans. It is the second leading cause of cancer death in American male Veterans. Metastatic castration resistant prostate cancer is lethal. Immunotherapies that are effective in other cancers, such as checkpoint blockade, are rarely effective in castration resistant prostate cancer. However, some patients with lethal prostate cancers who harbor certain molecular features may respond to checkpoint blockade. We will analyze the tumors of 200 Veterans with metastatic castration resistant prostate cancer for these molecular features that might predict response to checkpoint blockade. We will then conduct a Phase II clinical trial of checkpoint blockade with the drug pembrolizumab in these patients as well as further molecular assessments of the tumors to learn which patients respond best to this treatment.